Scaling Volumetric Imaging, Analysis and Science Communication Using Immersive Virtual Reality: Administrative Supplement

The original Phase IIb proposal addressed problems in analyzing, accessing and
communicating increasingly large 3D and 4D image sets in neuroscience. This supplement
request is motivated by two unforeseen developments since submission and review of the
original application. The requested activities are necessary to maintain the high overall impact of
the project. First, due to larger than expected positive response from educators who are
interested in testing the technology, we need to refine the active learning features for instructors
and student testers and advance performance monitoring to capture data rigorously. Second,
there has been a very rapid improvement in Foundational AI Models (FM) but which were not at
the appropriate stage of development to incorporate into our original application. We propose to
address these developments by seamless incorporation of performance monitoring into the
software, and by researching and integrating appropriate FMs into the user experience.

Public health relevance
Narration The goal of this work is to facilitate the communication of science to peers, the lay public, and in educational settings. Our mission is to improve learning and remembering of fundamental and challenging concepts, improve public debate relevant to these topics, provide new tools for students with learning disabilities, and deliver a tool that can make up for lost learning time during the Covid epidemic.